Autophagy-mediated defense against inflammation and cancer

Project Summary
Mounting evidence from our laboratory and others suggests that a lysosomal degradation pathway, called
autophagy, plays a central role in orchestrating inflammation and cancer biology. Recently, our laboratory
generated UVRAG (UV irradiation resistance associated gene) mutant mice that show normal levels of basal
autophagy but are deficient in stimulus-induced autophagy. With this mouse model, we demonstrate that
autophagy dysregulation could exacerbate inflammation and promote spontaneous cancers. However, major
gaps still exist in our understanding of intricate relationship between autophagy, inflammation and cancer,
including 1) what are the mechanisms by which inadequate autophagy perpetuates inflammasome response
and drives inflammation-associated pathologies? and 2) how does basal autophagy suppression affect tissue
homeostasis and promote cancer susceptibility? This project will fill these gaps by focusing on two Specific
Aims, including 1) investigating molecular mechanism of autophagy dysfunction on inflammatory signaling and
inflammation-associated pathologies; and 2) identifying molecular mechanism of autophagy inhibition in Wnt/b-
catenin signaling activation and spontaneous tumorigenesis. These aims will be addressed using
multidisciplinary innovative approaches that integrate state-of-the-art genetic, biochemistry, single cell analysis,
and physiological assays in cells, 3D organoid culture, and mice with targeted mutations in genes related to
UVRAG function and autophagy deregulation. Together, we anticipate that these studies will elucidate the
mechanisms underlying the intricate dialog between imbalance of autophagy, uncontrolled inflammation, and
spontaneous tumorigenesis, thereby providing important new insights into the functional repertoire of
autophagy and facilitating the development of much-needed new strategies for the treatment of inflammatory
pathologies and cancer, particularly those associated with autophagy defects.

Public health relevance
Project Narrative Autophagy deregulation has been implicated in excessive inflammation and tumor cell proliferation. However, the molecular mechanisms underlying these changes have yet to be well-identified. By using a unique mouse model with inducible expression of a cancer-derived autophagy inhibitor, this application aims to elucidate the mechanisms by which intervention with autophagy suppressor exacerbates tumor-promoting inflammatory response and promotes age-related spontaneous cancers, thereby providing the molecular basis for the development of novel therapeutics for autophagy-related pathologies and diseases.